Insulin and breast cancer: Implications for preventive counseling

As of August 2, 2007, we have recruited nineteen patients. Patient recruitment has been slowed due to the Clinical Center decision to stop payment for genetic testing. We are in the process of reassessing data analysis and protocol direction.